NMR of cell surface oligosaccharides

Project Summary/Abstract Cell-cell interactions are often mediated by the recognition of N- or O-linked glycans on cell- surface glycoproteins by endogenous lectins. These lectins are often themselves glycoproteins, anchored to cells by trans-membrane segments that generate intra-cellular signals. Glycan mediated interaction of multiple lectin molecules can, therefore, be an important element in regulation of cell to cell signaling. For the past several years this grant has supported the development of nuclear magnetic resonance (NMR) methods for the investigation of structural aspects of the interaction of isolated oligosaccharides with soluble lectins and applied them primarily to a subset of lectins that binds galactose terminated oligosaccharides. We now propose to extend these studies to lectins targeting sialic acid and fucose containing oligosaccharides, and to develop methods that will allow these investigations to proceed when the oligosaccharides are glycans covalently linked to glycoproteins. Modulation of immune response by specific cell-cell interactions is a good example where glycan mediated protein-protein interaction is an issue. B-cell activation is regulated by cis- versus trans- interaction of siglecs (sialic acid binding lectins) on the surface of immune cells. DC-SIGN (dendritic cell -specific ICAM-3 grabbing nonintegrin), a C-type lectin that binds fucosylated oligosaccharides and interacts with ICAM-3 (intercellular adhesion molecule-3) also is believed to modulate an immune response. The proposed studies will provide a structural basis for understanding of these important regulatory mechanisms. The studies will also lead to the development of new methodology that can be applied to a variety of other problems in human biology where glycans mediate protein-protein interactions. The specific aims include expression of siglec domain constructs suitable for NMR studies in glycosylated and non-glycosylated forms, remodeling of glycan residues on siglecs to improve glycan homogeneity and add isotopically labeled sialic acids, development of new NMR resonance assignment strategies for these labeled glycans, collection and interpretation of NMR data to define structure and dynamics of these glycans, and development of parallel strategies that would allow structural characterization of fucose containing glycans important to function of the DC-SIGN system.

Public health relevance
Project Narrative The interaction of cell-surface oligosaccharides with protein receptors is a primary means by which cells sense their environment. These can be beneficial in cases of detection and response to pathogens; it can be detrimental in aberrant response in autoimmune disease and inflammation. A structural understanding of the nature of these interactions is an important basis for the development of drugs that can modulate these responses. This project attempts to define the structural and dynamic characteristics of carbohydrate-protein interactions, not just with isolated carbohydrates, but with carbohydrates attached to the glycoproteins that are parts of communication pathways. New NMR methods for working with carbohydrates on glycoproteins are developed and applied to glycan-mediated interactions in systems important to immune response and human disease.